Community Engagement Core

ABSTRACT: CORE C The Community Engagement Core (CEC) facilitates the bidirectional exchange of knowledge between community-based and university-based scientists and researchers on environmental contamination and exposure pathways. As the hub for the partnership between the Yurok Tribe and UC Davis, the CEC works to identify community concerns and needs, facilitate response to those needs by working with the other project and core leaders, and ensure that the Tribe is able to engage with and participate in all projects of interest associated with the SRP. The expected outcomes of the CEC's activities are (1) tribal staff members trained in specific technologies for identifying specific contaminants and monitoring exposure pathways for those contaminants; (2) development of educational brochures and pamphlets for tribal members on specific contaminants; (3) technology transfer of specific tools to tribal staff and members to identify and monitor contaminants; (4) a cadre of university researchers trained to better work with tribes; (5) the collaborative acquisition of information on previously undocumented contaminants in the region; (6) provision of specific information on contaminants to support the Tribe's development of a pesticide ordinance and other specific policies, as needed by the Tribe. The process of the CEC begins with relationship building, leads to collaborative science, and concludes with benefits to both partners and the environment.

Public health relevance
PROJECT NARRATIVE: COMMUNITY ENGAGEMENT CORE The collaborative research led by the Yurok Tribe Environmental Program and UC Davis Superfund Research Center will result in the identification of specific contaminants, the ability to track their impacts on human and environmental health, and novel approaches to remediation and mitigation. The Community Engagement Core significantly contributes to the Superfund Research Center by working to develop meaningful bi-directional communication strategies between university and tribal researchers and community partners to apply UCD Center research to address community concerns. Broadly, the chemical detection technologies, remediation strategies and training opportunities aim to provide communities with autonomous methods for addressing environmental health problems within their community while training scientist on developing equitable, respectful, and responsible projects with community partners.